Equipment Supplement - Biosynthesis of marine terpenoid natural products

Project Summary
Natural product leads from marine life continue to inspire new drugs, with nine approved for
clinical use since 2010. A historical challenge with developing marine organism-derived bioactive
chemicals has been one of limited supply. Often, natural drug leads are isolated from rare or
environmentally sensitive marine invertebrates and algae, which challenges the pre-clinical
evaluation of promising candidates when demands outweigh natural supplies. Some terrestrial
plant-derived drugs can now be produced in genetically engineered microbial cell factories, an
approach that would be attractive for marine-derived molecules. However, the biosynthetic
machinery responsible for the biosynthesis of bioactive natural products in marine animals and
algae is largely unknown. Until now. We have discovered and validated the first steps of
biosynthetic pathways in corals and algae that lead to over 6,000 terpenoids, including the anti-
inflammatory pseudopterosin and anticancer halomon. We propose a multidisciplinary project to
investigate the molecular basis of terpenoid diversification in marine eukaryotes that harbor
terpenoids with promising biological properties. Significant outcomes of this research project will
include a new paradigm for terpenoid biosynthetic logic in marine eukaryotes, and the application
of this basic knowledge toward the microbial production of marine animal and algal molecules.
We propose three specific aims, namely: 1) To develop a marine eukaryotic genome mining
platform for algae and corals; 2) To functionally characterize marine eukaryotic terpene synthases
for high yield terpene production; and 3) To discover and characterize terpene tailoring enzymes
(halogenation/oxygenation) associated with bioactive coral and algal natural products.

Public health relevance
Public Health Relevance Statement Natural product compounds occupy a central role in medicine in providing lifesaving drugs. Supply challenges however often constrain the biomedical potential of promising bioactive natural products from rare or environmentally sensitive marine organisms. Our discovery of the first terpenoid biosynthesis genes in marine animals and amongst the first in marine algae towards flagship bioactive molecules like the anti-inflammatory pseudodopterosin and anticancer halomon offers a path to bioengineering drug leads from marine organisms from sustainable laboratory microbial fermentation.